CMV-specific CD19 CAR T cells amplified in vivo using CMV Triplex vaccine for B-NHL

PROJECT SUMMARY
Non-Hodgkin’s Lymphoma (NHL) is the most common hematological malignancy worldwide and represents the
6th leading cause of cancer deaths in the United States. Most patients with aggressive B-cell NHL (B-NHL) are
initially treated with combination chemoimmunotherapy, with ~2/3 cured. Standard 2nd-line treatment for patients
with primary refractory or early relapsed B-NHL is autologous CD19 CAR T cells, while for patients with later
relapse it is chemoimmunotherapy followed by autologous hematopoietic cell transplantation (auto HCT).
Although CAR T cells and auto HCT can potentially lead to cure, most patients will not achieve lasting remission
with either approach. CAR T-cell therapy is hampered by the limited persistence of CAR T cells in patients, and
their tendency, even when persisting, to become exhausted and lose their lymphoma-killing ability. We propose
a novel approach to improve the efficacy and durability of CAR T cells based on the properties of cytomegalovirus
(CMV)-specific T cells that we select and then expand using the Triplex three-antigen CMV vaccine developed
at City of Hope. Triplex has proven safe and powerfully immunogenic in both CMV-exposed and non-exposed
healthy volunteers and recipients of auto and allogeneic HCT in Phase 1 and 2 clinical trials at multiple US
cancer centers. Our approach entails selecting CMVpp65-specific T cells for modification with a CD19-targeting
CAR, infusing bi-specific CMV-CD19 CAR T cells into patients, and then inducing expansion in the patient by
stimulating the native CMVpp65-specific T cell receptor (TCR) using Triplex viral vaccine. The proposed strategy
is designed to enhance proliferation, lengthen persistence, prevent T cell exhaustion, and augment anti-
lymphoma activity of CMV-CD19CAR T cells by re-stimulating these cells through the native CMVpp65-specific
TCR. The long-term goal of this strategy is improved progression-free survival for B-NHL patients. In Specific
Aim 1 (SA1), we will test CMV-CD19 CAR T cell therapy followed by Triplex vaccine in 2 recently initiated pilot
clinical trials: 1) for patients with active relapsed/refractory B-NHL following lymphodepleting chemotherapy
(NCT05801913), and 2) for patients in 2nd remission to augment auto HCT (NCT05432635). The primary
objective is to establish safety and feasibility of the regimen. Secondary objectives are to evaluate clinical and
immunological response to therapy. In SA2, we will investigate cellular and molecular characteristics of the CMV-
CD19CAR T cell product including immunologic phenotype, functionality, and frequency of bi-specific vs mono-
specific target subsets. Following CMV-CD19CAR T cell infusion we will assess expansion kinetics and
phenotype of infused cells and their target subsets, pre- and post-Triplex vaccination. These studies will help us
to understand differences between TCR and CAR signaling and their impact on CAR T cell function. This strategy
is innovative because it provides on-demand vaccine-mediated expansion in the patient. This study will provide
proof-of-principle for a strategy of enhancing CAR effectiveness and augmenting T cell expansion, which could
have broad application across multiple targets and disease settings.

Public health relevance
NARRATIVE We are combining genetically engineered autologous immune T cells that respond to both lymphoma and cytomegalovirus (CMV) antigens, with a CMV vaccine that boosts T cell persistence and functionality in killing lymphoma cells. The main goal of this project is to minimize the relapse rate in patients with non-Hodgkin lymphoma undergoing second-line treatment. This strategy can be applied to other cancers in the future.